ShEEP Request for a high speed fluorescent slide scanning system

This proposal describes a request for funds to purchase the PerkinElmer Vectra Polaris high speed slide scanning system. The proposed equipment is a state-of-the-art system designed to provide high-quality- microscopy with increased sensitivity and faster throughput as well as automated functionality with large and secure data storage, which would allow VA investigators to image their samples within minutes instead of hours. This imaging system would allow the VA-funded investigators at the VA Boston Healthcare System (VABHS) to perform high throughput and super-resolution microscopy with high performance automated acquisition and analysis, including large scale quantification of markers, whole brain reconstruction and projection mapping. Acquisition of the system is supported by more than 6 VA-funded investigators at the VABHS. The proposed system will further research in multiple areas of study, such as gastrointestinal disease, neuroscience, and hematological malignancies. The present application describes our need for the proposed equipment, its technical specifications, information on how it can improve VA-funded research, and a plan for its administration.

Public health relevance
This application describes a request by the VA Boston Healthcare System (VABHS) for acquisition of the PerkinElmer brand Vectra Polaris Automated Quantitative Pathology Imaging System. The system provides top-of-the-line performance in acquisition speed and automated user-friendly functionality, and offers unrivalled breadth of capability, including whole-slide scanning and multispectral imaging, enabling identification and quantification of multiple overlapping fluorescent markers with autofluorescence reduction. The slide scanner works with the versatile specialized software HALO, to enable capabilities tailored to the needs of multiple labs and research interests. This fully-enclosed and automated system will enable VA-investigators to image tissues and markers with enhanced security and reliability. This level of imaging data acquisition is currently unavailable the VABHS, West Roxbury Campus. The system will be accessible to the largest number of VA users to facilitate VA funded research and benefit Veteran Healthcare.